Membrane-associated Steps in Coenzyme B12 Biosynthesis

DESCRIPTION (provided by applicant): Coenzyme B12 (aka, adenosylcobalamin, AdoCbl) is synthesized only by prokaryotes, and is essential to the survival of many pathogens. Hence, precise knowledge of the biochemistry underpinning this major pathway (~25 reactions), and an understanding of the structural properties of the enzymes involved, is critical to the design of inhibitors that could be used to target disease-causing bacteria or any other prokaryote of societal importance. I will apply a multidisciplinary approach to study the last step of AdoCbl biosynthesis, which is catalyzed by the AdoCbl-P phosphatase (CobC) enzyme. There are two parts to my proposal: i) Functional and topological studies of CobC; ii) analysis of interactions of CobC with other proteins suspected to comprise a multiprotein complex localized to the cell membrane. I will collaborate with structural biologists led by Ivan Rayment (Department of Biochemistry, UW-Madison) to gain insights into the mechanism of function of CobC, and to advance our understanding of the implications of the existence of a membrane associated biosynthetic complex. PUBLIC HEALTH RELEVANCE: Coenzyme B12 is only synthesized by prokaryotes, including many pathogens, and it is essential to the survival of animals, including humans. A better understanding of the biochemistry of coenzyme B12 biosynthesis will facilitate the design of antimicrobials that could be used to target disease-causing bacteria. In collaboration with others, our laboratory used knowledge gained from the studies of coenzyme B12 synthesis in our fight against cancer. A multifaceted approach will be applied to learn more about the last step of the pathway, which, in Salmonella enterica, it may occur outside the cell.

Public health relevance
PROJECT NARRATIVE. Coenzyme B12 is only synthesized by prokaryotes, including many pathogens, and it is essential to the survival of animals, including humans. A better understanding of the biochemistry of coenzyme B12 biosynthesis will facilitate the design of antimicrobials that could be used to target disease-causing bacteria. In collaboration with others, our laboratory used knowledge gained from the studies of coenzyme B12 synthesis in our fight against cancer. A multifaceted approach will be applied to learn more about the last step of the pathway, which, in Salmonella enterica, it may occur outside the cell.